New Mexico State University Laboratory Flexible Funding Model (U19)

Project Summary: Overall
The NMSU Food Safety Laboratory (FSL) will work towards achieving FERN objectives by ensuring that
trained staff are able to participate in FERN activities such as proficiency tests, evaluation of new
methodologies and analysis of surveillance and emergency outbreak samples.
The NMSU FSL proposes to improve our current Quality Management System by hiring a quality
manager to work with the NMSU FSL director, staff and APHL to achieve and maintain ISO 17025
accreditation.
The NMSU FSL proposes to partner with the New Mexico Indian Health Services and the New Mexico
Gaming Commission to collect food samples from New Mexico tribal nations. Until the IHS agreement is
in place, NMSU FSL could collect 200 papaya sample and 300 frozen tropical fruit samples and analyze
them for Salmonella enterica, Listeria monocytogenes and STEC until we establish our new sample
collection arrangement.
The NMSU FSL proposes to sequence a mixture of 400 or more pathogens and share the results (and
metadata) in real-time to the National Center for Biotechnology Information national database for
enteric pathogen genomes.
The NMSU FSL could better serve the FDA FERN if we could conduct additional analyses. The BAM
molecular detection procedure for Cyclospora cayetanensis is one method that we could establish in our
laboratory to provide testing support to the FDA in the event of a foodborne disease outbreak.
The NMSU FSL plans to collaborate with the New Mexico Indian Health Services to conduct sampling
within the NM Tribal Nations’ food supply.
The NMSU FSL proposes to participate in small‐scale method development/validation as a part of the
LFFM. We are proposing to participate in the MLV for qPCR method for Salmonella.

Public health relevance
Project Narrative: Overall The NMSU Food Safety Laboratory (NMSU FSL) will work towards achieving FDA FERN objectives by participating in FERN activities such as evaluation of new methodologies, analysis of surveillance and emergency outbreak samples, and whole genome sequencing. We will work to expand our testing capabilities to include molecular detection of Cyclospora. We are committed to food safety in the Indian Nations and will partner with New Mexico Indian Health Services for sample collection. The NMSU FSL will hire a Quality Manager to work with us to achieve and maintain the ISO 17025 accreditation of our lab.